Anga Center Community Collaborative Core

PROJECT SUMMARY
East Africa is in the midst of a climate crisis as one of the most vulnerable regions of Africa to climate change
(CC) and related extreme weather events (EWEs). CC will exacerbate already existing temperature extremes
and changes in precipitation in this region, and these environmental changes are likely to have a profound
impact on health and well-being. Even though countries and communities that contribute the least to CC are
often those most affected, there is limited inclusion of these communities in CC and health research. The Anga
Center for Climate Justice, Health Equity, and Community Wellbeing's central theme is to improve climate
justice, health equity, and community well-being by exploring climate-related health and well-being and
interventions to strengthen them through building transdisciplinary research capacity and fostering sustained
community engagement and empowerment in climate vulnerable communities and marginalized populations.
The Center's Community Collaborative Core seeks to improve local and regional CC and health science and
research by cooperating with and empowering community members from three East African (EA) nations
(Kenya, Uganda, and Tanzania) throughout the research process. One of our key strategies for achieving this
goal is to ensure the authentic collaboration of individual- and organizational-level stakeholders of populations
who face disproportionate vulnerabilities related to adverse CC and health outcomes: members of informal
settlements, pastoralists, and small-holder farming communities. Guided by community-based participatory
research (CBPR) and influenced by critical consciousness theory, gender transformative approaches, and
African Ubuntu philosophy, our Community Collaborative Core team will comprise 3 community collaborative
boards (CCBs) and a research team of 18 Field Managers and 36 community data collectors, in support of the
Center research projects. The problems addressed through the Core align with our Anga Center theme to
produce mutually beneficial, multi-directional relationships between communities and academic institutions in
the U.S. and EA. We will work together to facilitate multi-directional engagement and close collaboration
between community stakeholders, governments, partners in the humanitarian sector, and Center members to
identify common, actionable, community-defined priorities; solutions-oriented research questions and design;
and reporting/application of results, new strategies, and opportunities (Aim 1); employ, train, and empower
community members as research team members (Aim 2); and ensure culturally appropriate translation and
application of the Center findings and disseminate research results and evidence-based solutions to guide
equitable climate adaptation research and policy change in Kenya, Tanzania, and Uganda (Aim 3).
meaningfully engage community in all aspects of Anga Center research—leading to relevant outcomes that
can inform decisions to mitigate negative CC-related health impacts, disseminate educational tools and
materials, and promote global health equity.